STUDY OF DELAVIRDINE MESYLATE IN COMBINATION WITH DDI VS DDI ALONE IN HIV

This study will evaluate the safety, tolerance and pharmacokinetics of delavirdine in combination with ddI versus ddI alone in HIV-1+ individuals. It will also evaluate the efficacy of combination therapy with delavirdine mesylate plus ddI versus ddI alone based on changes in surrogate markers - CD4 counts, ICD p24 and p24 antigen level,plasma HIV 1 RNA and DNA by PCR.